Elucidating structures and molecular mechanisms of Pannexin channels

PROJECT SUMMARY
Purinergic signaling plays fundamental roles in activities of the nervous system as diverse as neuroprotection,
synaptic transmission, nociception, inflammation, and taste. This process is initiated by releasing adenosine
triphosphate (ATP) across the membrane through the classic exocytosis or ATP-permeable channels into the
synaptic cleft; the ATP then binds downstream receptors on an adjacent cell. The pannexin family is one of the
key ATP-permeable channels and consists of three family members, PANX1-3. PANX1 is the best characterized
functionally, and it plays crucial roles in a variety of contexts, including blood pressure regulation, glucose uptake,
apoptotic cell clearance, and human oocyte development. Although PANX2 and PANX3 have been less studied
than PANX1, they are important in neuronal development, ischemia-reperfusion injury, and skin/skeleton
development. Thus, the PANX channels have emerged as promising therapeutic targets for a diverse range of
diseases.
The PANX1-3 are nonselective, large-pore ion channels, and they are predicted to share a four-transmembrane-
helix (4-TM) topology with connexins, innexins, and volume-regulated anion channels. Biochemical and
physiological studies provide a consensus view that PANX family members form hexameric channels but do not
form gap junctions. PANX can be modulated by various factors, including mechanical scratch, extracellular
potassium, intracellular calcium, phosphorylation, and caspase-dependent cleavage, but the molecular
mechanisms aren’t known. PANX1 activity is modulated by a wide range of small-molecule compounds, but most
of them are not specifically targeting PANX1. There is currently no well-characterized agent that modulates the
activity of PANX2 and PANX3. Although PANXs are central to human physiology and are potential targets of
therapeutic agents, we do not know their structures. We do not understand, in molecular detail, how the channel
is activated or inhibited, or how it is modulated by small molecules binding at specific sites.
In this proposed work, we will carry out in-depth structural and functional studies of the three pannexin channels
to understand how these molecules work. We have determined the first cryo-EM structure of human PANX1 in
the apo state at 3.7 Å and found a heptameric assembly. We have also shown that human PANX1 can be purified
in a native-like lipid environment. Building on this preliminary data, we propose to continue the structural studies
of these family members, combined with complementary electrophysiology experiments, proteolipsome-based
dye transfer assays, binding assays, and other functional approaches, to define the molecular basis for a
comprehensive gating mechanism. We will also locate the binding sites of various drugs and the molecular basis
underlying their actions on PANX channels, using a combination of structural and functional approaches. These
advances will provide a solid foundation for developing new drugs against PANX-linked diseases and for a
deeper understanding of the function of the ATP release channel family.

Public health relevance
PROJECT NARRATIVE Pannexin (PANX1-3) are important ATP-release channels playing critically physiological roles ranging from blood pressure regulation, glucose uptake, apoptotic cell clearance, tumor metastasis, ischemia-reperfusion, human oocyte development to skin/skeleton development. The proposed study focuses on untangling the oligomeric state, channel assembly, molecular structure, gating mechanism, and pharmacology of the PANX1-3, taking advantage of single-particle cryo-EM, electrophysiology, and other functional approaches. The proposed research is relevant to public health and NIH’s mission because this work will provide a deep understanding and broaden our knowledge of the relationships between atomic structures and the complex biological and pathological functions of PANXs, paving the way for the development of therapeutics to treat pannexin-related diseases.